STRUCTURAL AND FUNCTIONAL ANALYSIS OF DROSOPHILA MYOSIN V

Myosin V functions as an actin-dependent ATPase. In Drosophila it is enriched in the brain. Identification of a mutant bearing a P-lacW insertion 600 bp from the ATG initiation site in the myosin V gene of Drosophila melanogaster has enabled us to study the effects of limited myosin V on the developing fly. Maternally contributed mRNA may support the survival of the homozygote mutant larva into the later larval stages since there are no apparent behavioral or developmental defects in either embryos or in early instar larvae. Neurological problems are first evident in the 3rd instar, where the distal portion of the larva is paralyzed, preventing them from righting themselves when turned on their dorsal side, and also decreasing the force and propagation of the peristaltic wave which propels them forward. These neurological defects are magnified in the adult stages in which mutants are slow moving and unable to jump or fly. Their wings are held at their side and are largely immobile. These phenomena are probably neurological, since they have normal muscle physiology as test by polarized light microscopy for birefringence. They also exhibit a general tremor of their head and legs. This chorea progresses rapidly, with newly hatched flies tending to move around at an almost normal rate, with movement becoming slower and less coordinated until death at 1 week. The mutants attempt grooming behaviors, but their movements are clumsy and slow. Additionally, no courtship behaviors are observed. Mobilization of the P-element has restored the wild type phenotype by precise excision. - unconventional myosin V; Drosophila; P-element; GST-fusion protein;